Randomized trial of a shared decision-making intervention for families about firearm storage

PROJECT SUMMARY
In the United States, firearm ownership is a protected right and valued by many people. Firearms are also the leading
cause of pediatric mortality. It is essential that in homes with children all firearms are consistently stored safely—which
means being stored locked and, in the safest scenario, unloaded. Firearm storage is a family-level safety practice, typically
involving multiple adults and more than one firearm, and safe storage is most likely when both members of parenting
dyads are involved in storage decision making. The American Academy of Pediatrics has highlighted the need for non-
judgmental family-centered interventions to help increase the proportion of firearms stored safely. To address this need,
we partnered with firearm-owning parents to develop the Family Safety Check-In, which is an interactive web-based
shared decision-making support tool that is tailored to different family structures and ages of children in the home. Pilot
data suggests that it helps facilitate informed, value-consistent decision making about storage in which all adult family
members are engaged in the decision-making process. Building from a successful pilot trial of the intervention, we will
address the following aims: (1) Translate and adapt the Family Safety Check-In to meet the needs of Hispanic, Spanish-
speaking families, working in partnership with an advisory board of eight Spanish-speaking Hispanic parents who have
firearms in the home. (2) Assess the effectiveness of the Family Safety Check-In on safe firearm storage practices in a
randomized controlled trial. Families will be recruited in conjunction with well-child/adolescent visits from practices in
the Washington, Wyoming, Alaska, Montana, Idaho Practice and Research Network (WPRN). All trial participants will
receive a firearm lock or lock box, with half also receiving the Family Safety Check-In for completion at home. The
primary outcome will be the change in storage practices at 6-month follow-up compared with baseline. (3) Test the theory-
driven family-level and dyadic mechanisms mediating intervention effectiveness. Actor-partner analyses will test the
pathways articulated in the logic model of change, including individual factors (e.g., feeling adequately informed) and
dyadic factors (e.g., communication satisfaction). Completing the proposed aims will produce necessary information
about the impact of the Family Safety Check-In on storage practices. Pending intervention effectiveness, clinic-based
dissemination and implementation will be a critical area for further study, including developing strategies to support
clinic-led dissemination.

Public health relevance
PROJECT NARRATIVE Firearms are the leading cause of pediatric mortality, and it is essential that in homes with children all firearms are consistently stored safely—which means being stored locked and, in the safest scenario, unloaded. To address this need, we partnered with firearm-owning parents to develop the Family Safety Check-In, which is an interactive web-based decision support tool that is designed to facilitate informed, value-consistent decision making about storage within families. In this study, we will evaluate the impact of Family Safety Check-In on safe firearm storage practices and dyadic decision making in a randomized controlled trial in English and Spanish-speaking families in the United States.